Target validation of CD206 activators

During this period, the collaborative team has worked to utilize microscale thermophoresis (MST) and biolayer interferometry (BLI) to probe binding and target engagement of CD206 inhibitors. Additionally, the team has identified novel CD206 activators through molecular modeling and medicinal chemistry efforts.

These molecules are being extensively investigated and characterized using in vitro and in vivo models to define effects on macrophage phenotypes and anti-tumor activity, towards development of a novel immunotherapy.